Trajectories to Heart Failure: Immunometabolic Mechanisms

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Trajectories to Heart Failure:
Immunometabolic Mechanisms, organized by Drs. Joseph A. Hill, Geneviève Derumeaux, Chiara Giannarelli
and Gabriele G. Schiattarella, with scientific programming input from Keystone Symposia. The meeting will take
place at Keystone Resort, Keystone, Colorado USA from February 10–13, 2025.
Metabolic alterations and inflammatory abnormalities are key contributors to the development of cardiovascular
diseases. Recent evidence shows that a chronic low-grade inflammatory response of metabolic origin, termed
“metainflammation,” is a defining feature of various cardiovascular diseases, including heart failure and
atherosclerosis. This pioneering international conference will bring together leading investigators in the areas of
cardiac biology, immunity, vascular inflammation and obesity-induced cardiovascular disease to elucidate
immunometabolic mechanisms in the trajectory to heart failure. For this reason, the conference will be held jointly
with another Keystone Symposium conference entitled Immunometabolism in Tissue Homeostasis and
Diseases. The program focus will span basic research through translational research and clinical insights, which
will expose attendees to a broad perspective on the important links between immune cell metabolism and
cardiovascular disease pathology. Ultimately, this meeting will support new collaborations that will contribute
significantly to understanding the immunometabolic underpinnings of cardiovascular disease and potentially
pave the way for innovative approaches in addressing cardiovascular health challenges.

Public health relevance
PROJECT NARRATIVE This first-of-its-kind international conference will focus on “metabolic inflammation” and its consequences in heart and vascular disease, a timely topic in light of the pandemic of obesity, metabolic stress and diabetes, which complicate cardiovascular health and limit the quality of life and longevity in patients across the globe. This conference, which will be paired with the Keystone Symposia conference on Immunometabolism in Tissue Homeostasis and Disease, will provide a comprehensive coverage of these topics by international thought leaders in a highly interactive and dynamic atmosphere. This cross-disciplinary meeting will foster new scientific relationships and encourage collaborations that will support a deeper understanding of the connections between inflammation, metabolism and cardiovascular diseases.